COVID supplement: Tetramer Research & Development

The NIH Tetramer Core Facility provides valuable resources to the research community that enable cutting edge research in basic immunology (such as SARS-CoV-2) and a wide variety of infectious disease areas via production and distribution of class I, class II and CD1 reagents. The reagents are being applied to studies of antigen processing and presentation, T cell activation, T cell responses against microbial pathogens or tumors, and T cell-mediated exacerbation or amelioration of immune-mediated diseases. This contract conducts research and development that would enhance the quality, functionality (e.g., sensitivity), and breadth of available tetramer reagents and decrease production time.